The role of epithelial barrier dysfunction in food anaphylaxis

Title: The role of epithelial barrier dysfunction in food anaphylaxis
Project Summary/Abstract
This K23 proposal comprises a five-year career development program designed to lead Charles F. Schuler IV,
MD into independence as a physician scientist studying the confluence of food allergy, mucosal immunology,
and epithelial barrier function. Dr. Schuler is an allergy and clinical immunology physician scientist with a long-
term goal of improving the diagnosis and treatment of food allergy. This proposal builds on Dr. Schuler's
experiences in laboratory and clinical research and leverages an existing human biorepository of samples from
food allergy subjects undergoing oral food challenges, the gold standard of food allergy diagnosis. This proposal
will proceed within the rich training environment at the University of Michigan Division of Allergy/Clinical
Immunology and Mary H. Weiser Food Allergy Center, combining the co-mentorship of James R. Baker Jr, MD
and Nicholas W. Lukacs, PhD with an outstanding advisory board of investigators. Dr. Schuler will follow a plan
of formal coursework, professional development, and mentored research to successfully grow into an
independent physician scientist.
This mentored research includes 2 scientific Specific Aims
 Aim 1: Determine the role of barrier gene variants in FLG, SPINK5, and JAM-A in food allergy
development.
 Aim 2: Examine the ability of net skin barrier measurements to predict or measure oral food
challenge outcomes.
Through completing these overarching Aims, Dr. Schuler will (1) evaluate how known and unknown variants in
these key barrier genes contribute to food allergy; (2), identify additional barrier-related genes that lead to food
anaphylaxis while seeking to construct a polygenic risk score for food allergy; (3), define the ability of trans-
epidermal water loss to identify patients at risk of food anaphylaxis; and (4) develop trans-epidermal water loss
as a real-time clinical measurement of anaphylaxis during food challenges.
The programmatic line of research established here will lead to several opportunities for R01 proposals. In
addition, the findings from this proposal will be validated using the Southeast Michigan Food Allergy
Collaborative birth cohort, a large-scale biorepository that is now in development. This work can also lead to the
development of non-invasive food allergy risk profiles to minimize the need for costly, cumbersome, and risky
oral food challenges. Further, through this work Dr. Schuler will develop research skills broadly applicable to
many different areas of allergy research. Thus, this K23 award will support and greatly accelerate the career
development of Dr. Schuler into a successful, innovative, and independent investigator.

Public health relevance
Project Narrative Food allergy affects nearly 10% of the United States population, and misdiagnosis leads to difficult, anxiety- provoking, and growth-limiting food avoidance. Current diagnostic tools are fraught with inaccuracy or require ingesting possible food allergens under medical monitoring, which is cumbersome, risky, and costly. The goal of this project is to understand the role of leaky skin and gut barriers in food allergy to develop more accurate and less onerous tests to diagnose food allergy.